Immune responses in the elderly to infection or vaccination

The contract seeks to identify the factors and mechanisms that contribute to 1) susceptibility to infection from or 2) limit the efficacy of vaccines against potential bioterrorism agents and emerging/re-emerging infectious diseases in elderly populations whose immune systems are compromised.